Locomotion adaptation deficits in older adults with mild cognitive impairment and Alzheimers disease

PROJECT ABSTRACT
Community walking function requires complex motor coordination, sensory feedback, dynamic balance,
adaptation to changing environmental stimuli, while also attending to tasks such as crossing a street or talking
over the phone. Unfortunately, cognitive dysfunction, the hallmark of mild cognitive impairments (MCI) and
Alzheimer’s Disease (AD), directly impacts the cognitive-motor neural resources available to carry out such
activities of daily living. The rigor of previous research shows that compared to healthy older adults (HOA),
people with MCI and AD walk slower, fall more, and have deficits in gait performance. Notably, gait
disturbances and changes in gait variability often precede cognitive decline. Thus, our overall goal is to
understand the effects of MCI and AD on gait function and locomotor flexibility, and the inter-relationships with
cognitive impairments. Locomotor adaptation is a fundamentally important process that enables humans to
flexibility respond to environmental demands, enabling normal community walking function. Split-belt walking is
a standardized, robust, well studied paradigm for quantifying capacity for locomotor adaptation, with potential
implications for walking function and fall prevention. Despite a large body of literature on split-belt adaptation in
individuals of multiple ages and neuro-pathologies, surprisingly, split-belt adaptation has not been assessed in
MCI and AD. A previous study showed reduction in the rate of split-belt adaptation when able-bodied
participants were distracted by a cognitive task, suggesting that adaptation processes interact with cognitive
functions. Another study showed multiple sessions of split-belt walking improved mobility outcomes post-
stroke, suggesting its potential as an exercise intervention. However, there is a knowledge gap regarding if and
how split-belt adaptation relates to cognitive deficits and walking function in individuals with MCI and AD. The
current R21 will build upon MPI Kesar and Nocera’s new published study that provides the first preliminary
evidence that split-belt adaptation is significantly impaired in people with MCI and AD compared to HOA. Our
premise is that in people with MCI and AD, reduced capacity for locomotor adaptation is a fundamental but
poorly understood mechanism that can be a sensitive biomarker of cognitive-motor impairments, and an
important therapeutic target for exercise-based interventions. Here, we propose the first comparison of split-
belt adaptation, in conjunction with comprehensive assessments of gait and cognitive function, in MCI, AD, and
HOA. We propose a unique combination of cross-sectional between-group comparisons (Aim 1) and repeated-
measures longitudinal time-point comparisons of disease progression (Aim 2). Aim 3 is a preliminary feasibility
study to guide future clinical trials on split-belt aerobic walking exercise interventions in MCI and AD. Further,
in parallel with locomotor adaptation (not previously studied), we will also evaluate walking function (gait
speed, gait endurance, mobility outcomes), gait performance (step length, gait variability, stride time), and
cognition in the same participant cohort, generating an innovative, rich, multi-modal dataset.

Public health relevance
NARRATIVE In conjunction with deficits in cognition, older adults with Alzheimer’s Disease (AD) and mild cognitive impairment (MCI) also show impaired walking function, which limits their community ambulation and quality of life. This project tests the hypothesis that the capacity to adapt or show flexibility in our walking patterns is an important factor that can affect mobility, by objectively measuring walking flexibility using a standardized lab-based test (split-belt adaptation) in people with MCI and AD, and also tracking if walking flexibility worsens with time or disease progression. Additionally, we will explore if split-belt walking exercise can be a safe, feasible, and effective exercise-based treatment to improve cognitive function and mobility in people with MCI and AD.